Minimizing the risk of therapy-related myeloid neoplasms by inhibiting genotoxic stress-induced expansion of leukemia-initiating cells with p53 mutations

ABSTRACT
Due to an ever-increasing number of cancer survivors, myeloid neoplasms associated with
chemotherapy and/or ionizing radiation are a significant concern for public health. Clinical data indicate
that the outcome for patients with therapy-related myeloid neoplasms (t-MNs) is poor, with a 5-year
survival of 10%. The unfavorable response of t-MNs to standard cancer therapies is largely due to
mutations in the tumor suppressor p53. It has been demonstrated that p53 mutant t-MNs are developed
through the expansion of rare tumor-initiating cells harboring pre-existing p53 mutations. Therefore, the
overall goal of this project is to prevent the development of p53 mutant t-MNs by inhibiting the
expansion of tumor-initiating cells and/or by selectively killing tumor-initiating cells at the premalignant
stage. To selectively target p53 mutant cells, we will use APR-246, a small molecule drug in clinical
trials that reactivates mutant p53 protein by restoring wild-type p53 conformation and function. We
hypothesize that treatment with APR-246 will prevent the genotoxic stress-induced expansion of p53
mutant HSPCs and selectively kill p53 mutant HSPCs that have expanded after genotoxic therapies.
We will test this hypothesis using a novel mouse model that we have developed in which rare HSPCs
expressing a p53R172H mutation undergo cell expansion after exposure to total-body irradiation in two
specific aims: Aim 1 – Evaluate the impact of APR-246 treatment during total-body irradiation on the
expansion of p53 mutant HSPCs and Aim 2 – Examine the effect of APR-246 plus azacitidine on killing
p53 mutant HSPCs that have expanded after total-body irradiation. We anticipate that the outcomes
from this proof-of-concept R03 grant will generate reproducible data that support further investigation of
utilizing APR-246 or other mutant p53 activators to minimize the risk of t-MNs in cancer patients who
show clonal hematopoiesis of mutations in the tumor suppressor p53.

Public health relevance
PROJECT NARRATIVE Recent deep sequencing studies indicate that a high risk of developing therapy-related myeloid neoplasms (t-MNs) is associated with the presence of clonal hematopoietic cells harboring pre-existing mutations in the tumor suppressor p53. However, no effective treatment is available to prevent the expansion of these tumor-initiating cells after genotoxic cancer therapies. I anticipate that the outcomes of this proposed research will identify novel therapeutic strategies that reduce the risk of t-MNs by specifically targeting p53 mutant hematopoietic cells.